Allosteric adhesins of enterobacterial pathogens

Abstract
This proposal seeks to identify potential allosteric properties in adhesins of human
enterobacterial pathogens - Escherichia coli, Klebsiella pneumoniae/oxytoca, Enterobacter spp, Proteus
mirabilis, and Salmonella – that are assembled via a chaperone-usher pathway (CUP). To date, only the
mannose-specific, type 1 fimbrial adhesin of E. coli, FimH, has been demonstrated to be an allosteric protein
that can exist in alternative functional (active/inactive) conformations. This property allows bacteria that contain
FimH as part of hair-like surface appendages, fimbriae or pili, to bind ligand presented on host cells rapidly
from an inactive conformation and to remain bound for very long lifetimes under shear force by transiting to an
active conformation. The long-lived (slow dissociation) binding involves formation of so-called `catch-bonds'
that can be activated and become stronger under tensile mechanical force and involve an allosteric switch. To
date no other bacterial adhesin has been demonstrated to be allosteric and to exist in alternative functional
(active/inactive) conformations. To identify other adhesins that work via similar mechanisms, we will focus on
adhesins that are part of fimbriae or pili and belong to the same CUP structural class as FimH. We recently
identified a set of aliphatic or aromatic residues that act as molecular toggles that control the allosteric switch
between active and inactive conformations by switching their orientation between the protein core and surface.
It is possible to stabilize either active or inactive conformation of the adhesin by “surface locking” such toggles
through substitution to hydrophilic charged residues. We will use putative analogs of the FimH toggles to
identify the existence of allosteric states in other CUP adhesins that are homologous or non-homologous to
FimH, using mutagenesis, various functional assays, and three types of structural analysis – NMR, X-ray
crystallography, and cryo-EM. Success of our studies will contribute to understanding of general mechanisms
of bacterial adhesion to host cells and, ultimately, to the design of optimized vaccines and small molecule
inhibitors. If certain adhesins are found to be allosteric, in-depth analysis of their physiologically-relevant
structure/functional properties and significance for pathogenesis as well as practical implementation of the
findings will be the focus of future studies.

Public health relevance
Narrative We propose to investigate the molecular mechanism by which bacterial pathogens attach to human cells and tissues. We will focus on hair-like attachment appendages that might bind to cell surfaces in a shear-modulated manner, by changing the shape of their binding proteins.